High-Resolution Peripheral Quantitative Computed Tomography (HR-pQCT) Scanner

Project Summary/Abstract
This application seeks funding to purchase a high-resolution, peripheral quantitative computed tomography (HR-
pQCT) scanner for studies with diverse goals such as improving musculoskeletal health, understanding the
signals in brain imaging, preventing post-traumatic osteoarthritis or the osteoarthritis that follows reconstructive
surgery of the anterior cruciate ligament, and identifying patients at risk of an osteoporotic fracture due to
hypertension or a pathological fracture due to bone metastasis. The scanner will be installed at the Vanderbilt
University Institute of Imaging Science and be managed by a shared resource or core called the Center for
Human Imaging. This core provides investigators at Vanderbilt University Medical Center (VUMC), Vanderbilt
University, and the local Veterans Affairs Medical Center access to multiple magnetic resonance imaging
scanners and a dual-energy X-ray absorptiometry scanner for research purposes, but without the non-invasive
HR-pQCT scanner, it lacks the ability to provide investigators the means to obtain high quality, volumetric images
of bone in humans. Because the radiation exposure is low and isolated to small regions, the scanner can be
used in longitudinal studies requiring serial scans. These images are comparable to the images that investigators
get scanning bones of small animals like mice. Moreover, the analysis software is the same between the human
scanner and the animal scanner making the transition from preclinical to clinical research seamless. By having
the HR-pQCT scanner available to multiple investigators, the impact of ongoing federally funded projects will be
enhanced because the instrument facilitates a direct translational pathway. For example, it provides
measurements of trabecular morphology such as bone volume fraction and trabecular number. It also provides
measurements of cortical structure and microstructure such as cross-sectional cortical area, cortical thickness,
and cortical porosity. Because the scanner is calibrated to a mineral phantom, all scans can be evaluated to
obtain measurements of volumetric bone mineral density. Moreover, the resolution of the scanner and the
accompanying software allows users to separate measurements of trabecular bone from cortical bone or to
combine measurements as a total. The software is also capable of converting the scans to computational models
that can estimate a subject’s bone strength. Such capabilities are state-of-the-art going beyond projection
measurements like areal bone mineral density, which cannot distinguish the contribution of cortical bone from
the contribution of trabecular bone to fracture risk. Being incorporated into an existing core that has strong
institutional support, a working plan is in place to provide financial and technical support of the new scanner as
well as a scheduling system that investigators can easily access to reserved time on the instrument. The HR-
pQCT scanner will support the ongoing investment of VUMC into advanced biomedical imaging techniques and
help scientist achieve their research goals.

Public health relevance
Project Narrative This funding request aims to improve the ability of investigators to translate their findings from NIH-supported projects to the clinic by obtaining a non-invasive scanner that measures many characteristics of bone that are determined in preclinical studies involving small animal models of disease. The scanner is designed for serial imaging of human forearms and legs, but it can also image postmortem bone and various anatomical sites of large animals. The high-resolution imaging capability of the scanner is needed to enhance the impact of ongoing projects investigating better ways to manage osteoporosis, osteoarthritis, consequences of severe injury, cancer metastasis to bone, and primary tumors as well as improve the understanding of the magnetic resonance signals from the brain and spinal cord.